Elucidating the mechanisms of protein secretion across the outer membrane by bacterial autotransporters

Project Summary/Abstract
Pathogenic Gram-negative bacteria are collectively responsible for over 5 million deaths annually. A number of
species also exhibit high levels of antibiotic resistance, comprising nine out of twelve members on the World
Health Organization’s list of priority pathogens. Gram-negative bacterial infection is often mediated by so-called
autotransporters, a class of proteins that cross the outer membrane to the extracellular space where they act
as virulence factors, such as adhesins, proteases, and other harmful agents. Autotransporters consist of a
translocator domain, which remains in the membrane, and a passenger domain, which secretes across the
membrane to the other side, even without the use chemical energy, e.g., ATP. Targeting these autotransporters
for inhibition represents a promising means of controlling infection while limiting the development of resistance.
However, first, research into the molecular mechanisms of autotransporter folding, secretion, and expression
beyond the cell surface is critically needed. This project will meet that need through three specific aims. In
the first aim, how the passenger domain folds will be characterized, answering why folding in vivo is orders
of magnitude faster than in vitro. The second aim focuses on the secretion of the passenger domain across
the membrane through a hybrid-β-barrel of the translocator domain with BamA, the protein responsible for its
membrane insertion. The pathway through the combined barrels will be determined, as well as the influence of
the outer membrane on the process. In the third aim, another class of autotransporters, two-partner secretion
systems, will be modeled, with a goal of identifying both commonalities and differences between them and other
classes. The primary methodological tool to be used for this project is atomic-scale molecular dynamics (MD)
simulations. These simulations will all be carried out in realistic environments, including an accurate model of the
asymmetric Gram-negative outer membrane. Multiple innovative approaches will also be used, including deep
learning for modeling the folding process, Markov state modeling for extracting kinetics information, and coarse-
grained Brownian dynamics for observing spontaneous secretion. Close collaboration with multiple experimental
labs will provide key inputs to and validation of the MD simulation results.

Public health relevance
Project Narrative The threat posed by Gram-negative bacteria is significant and growing due to the spread of antibiotic resistance. Infection by these pathogens is often mediated by virulence factors known as autotransporter proteins. This project will determine the atomic-level details of autotransporter folding and expression, thus providing a basis for novel antibacterial interventions.